The regulatory impact of transposable elements (TEs) on differential gene expression in closely related species during cellular differentiation

Abstract
Environmental factors contribute to the susceptibility of developing heart disease, but the same factors do not
equally increase the disease risk for all people. Understanding how almost identical DNA between individuals
provides so much variation in physiological and pathological presentation is essential to predicting a person’s
risk of heart disease correctly. Differential gene regulation is a strong candidate for explaining these observed
variations. Transposable Elements (TEs) comprise fifty percent of primate genomes but have long been
considered “junk” DNA. However, recent studies have shown that TEs play a role in gene regulation in terminally
differentiated cells between humans and chimpanzees, whose genomes share 98% similarity. Other studies
have also demonstrated that differential silencing of TEs between humans and chimpanzees does not contribute
to differential gene expression between the species' induced pluripotent stem cells (iPSCs). A knowledge gap
exists regarding the developmental stage when TEs might begin to explain species-specific gene expression
differences. I hypothesize that TEs have played a significant role in generating differences between primates
through species-specific gene regulation throughout cellular differentiation. Aim 1 is to define the roles of TEs
in species-specific gene regulation as iPSCs differentiate into cardiomyocytes. I will differentiate and
collect human and chimpanzee iPSCs as they progress from pluripotency to mesoderm, cardiac mesoderm, and
cardiomyocytes. Cellular phenotypes will be resolved through RNA sequencing, and differential gene
expressions between species will be determined. To assess which regions of DNA have active (H3K27ac) and
repressive (H3K9me3) chromatin modifications, Cleavage Under Targets and Tagmentation (CUT&Tag) will be
performed in both species. I will overlap DNA regions with active and repressive histone modifications to the TE
annotation file, RepeatMasker, to identify TEs in regulatory proximity to differentially expressed genes. Aim 2 is
to discover the roles of TEs in differential gene expression between closely related species during the
early embryological event of mesoderm specification. Human and chimpanzee iPSCs will be differentiated
into the mesoderm, endoderm, and ectoderm lineages. The contribution of TEs to differences in early regulatory
events between species will be assessed through the approaches discussed above, comparing mesoderm to
the other germ layers to determine lineage-specific effects. Through the abovementioned project, I will gain skills
in iPSC cell culture, differentiation techniques, and assays to assess epigenetic gene regulation. I will also
develop expertise in utilizing computational approaches for processing RNA-sequencing data and developing
pipelines to compare expression and gene regulatory features across species, necessitating the identification of
orthologous regions and genes for direct comparison. These skills will prepare me for my long-term goal of
becoming an independent genomics and cardiovascular research scientist.

Public health relevance
Project Narrative Understanding how phenotypes vary between and within species despite high degrees of DNA similarity continues to limit our ability to predict disease susceptibility and severity. Transposable elements can regulate gene expression between different tissues within a species and the same tissue between species. By understanding the role TEs play in generating different phenotypes in human and chimpanzee heart-relevant cell types, we can bridge the gap between knowing the DNA sequence and predicting an individual’s disease risk and presentation.